Harnessing immune-epithelial interactions to promote restoration of salivary gland function after IR

Abstract:
More than 73% of head and neck cancer patients continue to suffer from the chronic consequences of xerostomia
months to years after the completion of radiotherapy making this one of the most compelling issues in salivary
gland biology. Despite technological advancements in cancer therapies, collateral damage to salivary glands
remains a significant problem for these patients and severely diminishes their quality of life. The field of radiation-
induced salivary gland damage is severely hampered by the lack of a comprehensive model detailing the
molecular stages of damage. The overall vision (long-term goal) is to restore salivary gland function in patients
following radiotherapy by identifying mechanisms that regulate stages of dysfunction in salivary glands. Our prior
work has demonstrated that mouse parotid glands 10 months after fractionated radiation have significant
increases in T cell populations (CD4+, CD8+, CD4+CD8+, and FoxP3+ T cells), suggesting immune populations
may play an active role in the chronic loss of salivary gland function. We hypothesize that radiation treatment
leads to chronic dysregulation of metabolic pathways in T cells resulting in prolonged activation of CD4+CD8+,
double positive (DP) T cells that inhibit salivary epithelial regeneration and repair. We propose to develop a
kinetic model of the metabolic phenotype of infiltrating immune populations and how immune-epithelial
interactions contribute to chronic loss of function. The outcomes from this work include: 1) immunometabolic
phenotype and the function of T cells following radiation, 2) the effect of modulating T cell metabolism on repair
of damaged glands, 3) cellular identity of immune populations surrounding damaged epithelial cells, 4) impact of
immune cell metabolic phenotype on the ability of Metformin to reverse salivary gland dysfunction.
Understanding this process would have a positive impact by revealing intervention points that promote
restoration of salivary gland function.

Public health relevance
Radiation is a common treatment in most head and neck cancer cases and results in the long-term loss of saliva for more than 73% of patients. The resulting lack of salivary gland activity results in significant adverse side effects, which diminish the effectiveness of anti-cancer therapies, and decreases the quality of life for these patients. The goal of this proposal is to understand how immune cells affect the wound healing process in irradiated salivary glands and these studies could have the potential to find new therapies to restore salivary gland function to patients with chronic dry mouth.